Collaboration on HIV and AgingResearch through the Study of Mitochondria

ABSTRACT
Jing Sun is a physician epidemiologist and Assistant Scientist in the Department of Epidemiology at Johns
Hopkins Bloomberg School of Public Health. She seeks a mentored career development award to fill knowledge
gaps in her current training, allowing her to develop as an independent molecular epidemiologist who can bridge
the diverse fields of HIV epidemiology, genetics / epigenetics, and aging to improve long-term outcomes among
people with HIV (PWH). Since the advent of effective antiretroviral therapy, there has been a rising burden of
aging-related conditions among PWH. Mitochondrial damage is a major driver of aging, but its role in HIV and
aging has been understudied. Leveraging data, infrastructure, and the biospecimens of two long-term HIV
cohorts (ALIVE and MACS), Dr. Sun will define the relationship between mitochondrial DNA copy number, a
noninvasive marker of mitochondrial content, and biological aging at the phenotypic, molecular, and
immunological levels among people with and without HIV (Aim 1). She will further define the interrelationship of
mitochondrial DNA copy number with DNA methylation and nuclear genetics using existing data from ALIVE and
MACS (Aim 2). In Aim 3, she will design a study nested within an ongoing exercise intervention trial to evaluate
the effect of exercise on mitochondrial function, methylation patterns, and physical function among PWH. To
complete these research aims and develop an independent research program, Dr. Sun will receive training in
the following areas: (1) statistical genetics and multi-omics analysis; (2) laboratory measurement of mitochondrial
function; (3) biobanking and management; (4) research leadership. The training program consists of didactic
coursework and seminars, hands-on practice in statistical genetics analysis, informational laboratory visits and
shadowing, participation in a certificate program, and mentored research by an established and diverse team of
senior investigators. Completion of the proposed aims will directly address important epidemiological,
mechanistic, and interventional knowledge gaps and elucidate the role of mitochondrial function on biological
aging among PWH. Findings will provide evidence for targets of future clinical and interventional research with
the potential to guide long-term management and improve quality of life among PWH. Preliminary data and
research capacity built through this K01 award will support an R01 investigating the role of mitochondrial function,
aging, and comorbidities among PWH using a multi-omics approach. It will further support Dr. Sun’s long-term
career goals to become an international leader in HIV and aging with content expertise in mitochondrial genetics
and function.

Public health relevance
NARRATIVE/RELEVANCE The lifespan of people with HIV has been considerably extended, but the burden of age-related comorbidities remains high among them. This proposal will evaluate the role of mitochondrial function and DNA methylation in biological aging (represented by frailty phenotypes, epigenetic clock acceleration, and immunosenescence) among people with HIV, as well evaluate the potential of exercise to reverse mitochondrial function damage and epigenetic clock acceleration caused by HIV. Completion of this proposal will enhance the understanding of the role of mitochondrial function in age acceleration among people with HIV as well as highlight potential interventions to mitigate the damage, which ultimately could lead to improvements in treatment and long-term care strategies for people aging with HIV.